HuR-Wisp1 signaling in cardiac fibroblasts

SUMMARY
The development and regulation of cardiac fibrosis is influenced by the phenotypic activation of quiescent
cardiac fibroblasts (CFs) to active myofibroblasts (MFs). These two distinct cell types play key roles in
maintaining the homeostasis of extracellular matrix (ECM) remodeling and contractile functions of the heart.
Preliminary data from our lab demonstrates that HuR is necessary for CF-to-MF activation in vitro and identified
Wisp1 as a HuR-dependent gene capable of independently inducing MF activity.
The goal of this proposal is to determine the in vivo role of HuR-Wisp1 signaling during pathological
cardiac remodeling and the potential for targeting HuR and/or Wisp1 as a means to mediate resolution of the
active MF phenotype. We hypothesize that HuR-Wisp1 signaling in cardiac fibroblasts is essential for
myofibroblast activity and promotes pathological cardiac remodeling in vivo. Aim 1 will utilize new mouse models
created by our with a CF and MF-specific deletion of HuR to determine its functional role in cardiac fibroblasts
during pathological cardiac remodeling following pressure overload. Aim 2 will then identify the functional and
mechanistic role of HuR-dependent control of Wisp1 expression on the initiation and resolution of MF activity.
Overall, this work will enhance our understanding of the functional impact of HuR-Wisp1 signaling on
fibroblast function during pathological cardiac remodeling and guide potential future therapeutic manipulation of
HuR or HuR-dependent gene expression in cardiac remodeling.

Public health relevance
PROJECT NARRATIVE This proposal is centered around determining the role of an RNA binding protein, HuR, in cardiac fibrosis. Preliminary data suggests that HuR is involved in the propagation of pathological fibrosis through stabilizing the upregulation of extracellular matrix proteins. Therefore, we believe a fibroblast specific deletion of HuR will be cardio-protective and further HuR as a therapeutic target.